CSHL 2025 Telomeres & Telomerase Conference

Cold Spring Harbor Laboratory Conference on Telomeres and Telomerase
April 29 - May 3, 2025
Abstract
Telomeres are specialized protein-nucleic acid structures that protect the ends of
linear chromosomes. In most eukaryotes, telomeres contain short DNA repeats that are
replenished by the enzyme telomerase reverse transcriptase. It has long been recognized
that age and replication-associated telomere shortening is a driver of cellular and
organismal aging processes, and that telomere length and integrity are regulators of life
span. Short or dysfunctional telomeres drive cells into senescence or cell death and are
causative for numerous age-associated pathologies in humans, ranging from stem cell
dysfunction, cognitive disorders and dementia to the age dependent increase in cancer.
Mutations in several genes involved in telomere maintenance result in accelerated
telomere shortening and are causative for a group of telomere biology disorders including
dyskeratosis congenita. Mutation carriers age prematurely and have a reduced lifespan,
emphasizing the importance of understanding telomere function in regulating human
health span and prevention of age-associated pathologies. Consequently, the telomere
field has evolved to represent a wide variety of research areas in which telomeres play
crucial roles (aging, telomere syndromes, stem cells, cell cycle progression, cancer,
meiosis and fertility, recombination, replication). The field encompasses clinical studies,
as well as fundamental and pre-clinical research with a wide variety of model organisms
including budding yeasts, fission yeasts, protozoa, mice, plants, nematodes, flies, birds,
and frogs. This meeting focuses on understanding the roles of telomeric proteins in cellular
pathways that regulate genome integrity, on progress in the fields of telomerase
biogenesis and regulation, on the roles of telomere maintenance pathways in aging and
immortality, and on telomere dependent pathologies as functions of telomere length,
integrity and organismal age.
The previous thirteen Cold Spring Harbor Laboratory meetings on Telomeres and
Telomerase have served a pivotal function in bringing together a diverse group of
researchers from all parts of the world and have been characterized by vigorous
discussions and synergistic interactions stimulated by the presentation of mostly
unpublished data. Because the CSHL Telomeres and Telomerase conference remains
the only opportunity for scientists in this rapidly growing field to interact as a whole, this
meeting is unique and of the utmost importance for the future of the field. Moreover, the
format of CSHL meetings, for which nearly all talks are chosen from submitted abstracts,
maximizes the opportunity for new independent investigators, postdocs and graduate
students to present their work in a highly visible venue. The meetings have all had a
uniformly high attendance rate from an international group of researchers, and the podium
and posters have consistently introduced major discoveries in the field well before their
publication.

Public health relevance
Project Narrative The ends of chromosomes have long been recognized as key regulators of the cellular and organismal aging process. Telomeres, the specialized nucleic acid – protein complexes that assemble at chromosome ends, protect those ends from threats to their integrity, like degradation or fusion and thus play a key role in ensuring genome stability. Indeed, chromosomes cannot be duplicated or distributed accurately during cell division without perfectly functioning telomeres. As cell proliferation is directly linked to telomere shortening, telomeres have been recognized as a molecular clock that regulates cellular life span. Replication of the highly repetitive telomeric DNA also provides an obstacle to the replication machinery itself. The replenishment of telomere sequences is primarily the task of the enzyme telomerase, and secondarily occurs by recombination. These activities directly link aging, immortality, and cancer to chromosome end maintenance. The field of telomere and telomerase biology has grown rapidly since it was recognized that telomeres play such a pivotal role in cellular aging, stem cell maintenance and cancer. As a result, the telomere field is now a highly diverse and dynamic research community, representing a wide variety of research interests and disciplines. These include telomere syndromes causing premature aging, bone marrow failure, liver cirrhosis, aplastic anemia, lung fibrosis and cancer. The Cold Spring Harbor Laboratory conference on Telomeres and Telomerase is the single most important meeting in this field. It brings together a diverse group of researchers from around the world who use a comprehensive set of approaches ranging from single molecule biophysics and biochemistry to studies of patients harboring mutations in genes involved in telomere maintenance. Since most oral presentations are chosen from submitted abstracts, the meeting provides the opportunity for a diverse group of researchers at all career levels to present their latest findings to the entire telomere field, the leaders of which participate vigorously in the conference. The 2025 meeting is on track for the presentation of a large body of unpublished data resulting in intense discussions and synergistic interactions.